ELECTROPHYSIOLOGY CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Epithelial Electrophysiology Core provides the instrumentation, expertise, training and mentoring in epithelial electrophysiology necessary for COBRE projects. COBRE and KSU projects use Core resources to make non-invasive current and non-radioactive ion flux measurements. The facility supports a vibrating current-density probe and self-referencing ion-selective electrodes, and provides technical support to investigators.